Targeting tumor and its microenvironment using nanotherapeutics for pancreatic cancer

ABSTRACT
Pancreatic cancer (PC) is lethal with a five-year survival rate of less than 9.2 % and a median survival of 5-6
months. The limited efficacy of mono-therapies has led to the exploration of combination therapies with limited
success because of challenges associated with dose-limiting side effects, drug-associated toxicities, drug
resistance, and poor pharmacokinetics. Importantly, these past approaches have not attempted the concurrent
targeting of the pancreatic tumor and its stroma and PC stem cells. Our proposed work addresses these
challenges by determining functional and clinic-pathological significance of miR-345 as well as developing a dual
delivery nanoscale device (DDND) for combined delivery of miR-345 and GEM for the treatment of PC. Our
preliminary studies have shown that miR-345 targets several important genes, including sonic hedgehog (Shh),
Kras, MUC4 mucin and its downstream targets, genes-associated with cancer stem cells (ALDH1, ESA, Hif1α,
and Oct/3/4), and causes up regulation of cleaved caspase-3, -7, and PARP. The Kras, Shh and MUC4-signaling
play critical roles in tumor growth and metastasis by promoting epithelial to mesenchymal transition (EMT), PC
stem cells, angiogenesis, desmoplasia, which limit the delivery and efficacy of chemotherapy. MiR-345 targeting
Kras, Shh and MUC4, which makes miR-345 is an excellent candidate for diagnostic/prognostic and therapeutic
targets in PC. We hypothesize that downregulation of miR-345 contributes to PC pathogenesis by upregulation
of Kras, SHH, and MUC4; Its restoration, combination with GEM through the DDND, enhances GEM sensitivity
in PC through modulation of SHH/Kras/MUC4 pathways, resulting in inhibition of desmoplasia, pancreatic stellate
cells, and PC stem cells leading to an improved therapeutic outcome of GEM in PC through improving its tumor
perfusion. The DDND is based on temperature and pH responsive pentablock copolymers electrostatically
complexed with miR-345 and subsequently self-assembled with GEM encapsulated layers. The DDND design
allows effective co-incorporation of miRNA/GEM combination; facilitates cellular entry; enhances stability
compared to liposomal carriers; provides miRNA protection; allows targeting by selectively facilitating endosomal
escape in cancer cells as opposed to normal cells by exploiting intracellular pH differences; and allows dose-
sparing of the cytotoxic drugs. Aim 1 will focus to determine functional role and clinico-pathological significance
of miR-345/Shh/Kras/MUC4 axis in highly aggressive and metastatic PC. Aim 2 will focus on the development
of DDND loaded miR-345/GEM as a novel therapeutic agent against lethal PC by evaluating their therapeutic
efficacy in vitro. In the final Aim 3, we will evaluate therapeutic efficacy of DDND loaded miR-345/GEM alone or
in combination in mouse models. Altogether, the proposed work decipher the clinic-pathological significance of
miR-345 and expected to significantly advance the goal of combining GEM and miR-345 delivery for treatment
of PC patients, enhance understanding of the synergistic mechanisms involved, and will provide a novel DDND
design for delivery of other therapeutics as well in the future.

Public health relevance
PROJECT NARRATIVE This project is focused to determine functional and clinicopathological significance of miR-345 as well as development of novel combination therapies involving miR-345 restoration and gemcitabine therapy. The dual- delivery nanoscale device (DDND) loaded with miR-345 and GEM therapy concurrently targets pancreatic tumor cells and its stroma as well as pancreatic cancer (PC) stem cells by downregulating SHH, Kras and MUC4 for efficacious treatment of PC thereby overcoming challenges associated with current PC therapies.